Role of epicardial adiposity as a local mediator of VT/VF dynamics in donor human hearts

Project Summary:
Ventricular tachyarrhythmias are responsible for 300,000 sudden cardiac deaths a year in the US. The
mechanisms underlying these arrhythmias in the majority of cases are ventricular tachycardia (VT) and/or
ventricular fibrillation (VF). The ever-increasing prevalence of obesity also poses a significant burden on
the health care system with increased morbidity and mortality. Importantly, obesity has been associated
with cardiac arrhythmias with increased risk of sudden cardiac death linked to increased adiposity.
However, the mechanisms by which obesity could result in ventricular arrhythmias (VT/VF) remain
incompletely understood. In this proposal, I plan to use a multimodal and multiscale approach to
characterize VT/VF in donor human hearts associated with sustained obesity. In the mentored phase of
this project, I will use donor hearts to investigate the role of epicardial adiposity in promoting VT/VF via
paracrine signaling, while also getting specialized training in bioinformatics and adipocyte biology. In the
independent phase of this project, I will use donor hearts to investigate the role of epicardial adiposity in
generating arrhythmogenic triggers. The experiments outlined below will advance our understanding of
VT/VF mechanisms and also serve as proof-of-concept for future experiments designed to develop new
markers to predict and treat VT/VF vulnerability in a clinical setting.

Public health relevance
Project Narrative: Ventricular tachyarrhythmias are responsible for 300,000 sudden cardiac deaths a year in the US. In addition, the ever-increasing prevalence of obesity also poses a significant burden on the health care system with increased morbidity and mortality associated with fatal ventricular arrhythmias. In this project, we will a multi-modal and multi-scale approach to characterize how obesity induces ventricular arrhythmias in donor human hearts and use that knowledge to potentially develop new markers to predict and treat ventricular arrhythmias in a clinical setting.